Antibody biomarker discovery for current and recent asymptomatic malaria exposure

PROJECT SUMMARY/ABSTRACT
There is a pressing need for sensitive, field-deployable malaria surveillance tools to guide the optimal
deployment of interventions in elimination zones, where transmission is focal and malaria risk heterogeneous.
Ultrasensitive molecular methods have revealed that most malaria infections in these settings are subclinical,
low-density infections, which are not detectable by standard diagnostic tests, serving as a silent reservoir for
malaria transmission. However, ultrasensitive molecular methods are expensive, time-consuming, require a well-
equipped laboratory, and thus cannot provide point-of-contact results, limiting their utility in remote malaria-
endemic areas. An ideal surveillance tool would not only measure parasite prevalence, but also estimate recent
malaria exposure, providing a more robust characterization of malaria in a population. Antibody biomarkers are
promising targets for malaria surveillance in this setting because they can indicate cumulative exposure and are
easily integrated into existing point-of-care platforms. However, serological markers remain underutilized due to
a lack of well-defined targets or consensus on how to interpret results. Many of the most seroreactive malaria
antigens are also the most polymorphic, confounding results based on reactivity to reference-strain proteins.
This work proposes to leverage this diversity to identify informative antibody biomarkers to estimate malaria
exposure. Based on our preliminary data, the central hypothesis of this proposal is that individuals exposed to
low-density malaria infections have unique serological profiles that can be used for rapid evaluation of recent
and current exposure. This hypothesis will be tested with the following specific aims: 1) Identify antibody
biomarkers for current and recent (6 months) subclinical Plasmodium falciparum and Plasmodium vivax
exposure, and 2) validate novel peptide targets against malaria antigens using a multiplexed bead-based
immunoassay format. In Aim 1, antibody biomarkers will be identified by measuring seroreactivity of matched
exposed and unexposed individuals on novel ultra-dense peptide arrays populated with sequences from
Plasmodium falciparum and Plasmodium vivax antigen variants from both reference strains and geographically-
relevant field isolates. In Aim 2, down-selected peptides will be synthesized in bulk and conjugated to barcoded
magnetic beads for a multiplexed fluorescence-based immunoassay. Seroreactivity to peptide targets will be
measured on well-characterized samples from individuals with known malaria exposure as well as endemic
controls. The proposed work is the first step toward developing a robust point-of-contact test that can be used to
characterize malaria transmission and risk, ultimately enabling better and more precise targeting of interventions.

Public health relevance
PROJECT NARRATIVE In low-prevalence settings, malaria elimination requires precise targeting of interventions based on up-to-date surveillance data. Serological biomarkers are promising targets for malaria surveillance because they reveal past exposure in addition to current infection status, adding substantially more information to population-level measures of transmission. This work aims to identify and validate antibody biomarkers for current and recent asymptomatic malaria infections, which would be the first step toward developing a rapid and robust serological test for malaria exposure.